A SARS-CoV-2 NFC ePAD Biosensor

Proposed here is the development of an improved electrochemical sensor for detection of
the SARS-CoV-2 nucleocapsid protein using thermoplastic electrodes (TPEs). The need for faster
testing amid the COVID-19 pandemic brought about several alternatives to RT-qPCR testing for
viral infections. However, current rapid tests are lacking in sensitivity (lateral flow assays and
other paper based tests) or expensive (gold based electrochemical tests). TPEs solve both the
sensitivity and cost issues and have been shown to be more robust than stencil printed carbon
electrodes (SPCE). The TPE surfaces will be covalently modified using electroreduction of
aryldiazonium salts followed by “click chemistry” to provide a platform for simple antibody
crosslinking reactions. The fully characterized and functional sensor will then be the basis for
future work integrating it into a microfluidic device for a full on-chip assay.

Public health relevance
Project Narrative The current COVID-19 outbreak has begun to reshape how we think about and use diagnostic assays for preventing the spread of infectious diseases. The ideal diagnostic would determine if an individual is currently infected or has been infected in the past with accuracy and sensitivity, be simple enough to use at most any location, and be cost effective to allow for widespread deployment. We are developing a novel diagnostic platform to meet this demand that combines a revolutionary disposable near field communication potentiostat with an electrochemical paper-based analytical device for detecting circulating SARS-CoV-2 antigen and antibodies.